Platinum-Gold Compounds as Potential Chemo- and Targeted Agents for Ovarian Cancer

PROJECT SUMMARY
Ovarian cancer (OC) is the fifth in cancer mortality for women, and it is the deadliest for all types
of gynecological cancers, affecting mainly postmenopausal women. In 80% of the cases the
diagnosis comes at stages III and IV with 28% survival rate. The standard of care of OC is
debulking surgery followed by platinum-based chemotherapy. FDA-approved platinum (II)
compounds (cisplatin, carboplatin and oxaliplatin) present major drawbacks for OC which are: a)
the acquired resistance of cancer cells after treatment, and b) the lack of selectivity which causes
undesired secondary effects due to dose limiting effects. For as many as 62% patients the disease
will recur after receiving chemotherapy, and maintenance therapies are required. Modified Pt(IV)
compounds hold the potential to become alternatives to Pt(II)-based drugs, especially for OC, for
which resistance to the treatment is a major problem, and for which first-line chemotherapy
treatment may still be the most affordable option for years. This proposal aims to develop Platinum
(IV)-Gold anticancer agents with potential dual- or multi-drug effects with improved
pharmacological profile with respect to FDA-approved Pt(II) compounds. Our hypothesis is that
the reduction of the heterometallic Pt(IV) compounds inside OC cells, will release not only
conventional Pt(II) anticancer agents, but also highly cytotoxic gold derivatives that will target
different biomolecules in the tumors and favor immunogenic cell death, overriding resistance. The
specific aims of this proposal are: Aim 1. Synthesis and in vitro Evaluation of New Platinum(IV)-
Gold Compounds in Ovarian Cancer Cell Lines. We will synthesize new Pt(IV)-Au(I) and Pt(IV)-
Au(III) compounds and study their stability and interactions with DNA (target for Pt(II)
compounds). We will evaluate their effects on a panel of epithelial ovarian cancer cell lines with
varying degrees of genetic complexity, as well as on non-tumorigenic cell lines. For selected
compounds, we will study their effects on other cancer hallmarks (migration, invasion and
angiogenesis), on cell death and cell cycle, and inhibition of gold compounds’ targets. Aim 2.
Optimize the Formulation and Targeting Properties of Selected Pt-Au Compounds. Preliminary in
vivo Investigation. We will encapsulate best performing Pt-Au compounds into liposomes and
immunoliposomes to further improve the safe delivery of these derivatives. In addition, we will
assess the survival of mice treated with two selected Pt-Au compound and their two formulations
(Pt-Au-Lip and Pt-Au-ImmunoLip) on a mouse metastatic orthotopic model (ovarian cell line
resistant to cisplatin, C200) and compare it to that of those treated with cisplatin and carboplatin.

Public health relevance
PROJECT NARRATIVE The work proposed is relevant to public health, since it will help advance the development of metal-based cancer chemotherapeutics for ovarian cancer with improved pharmacological and clinical profiles than drugs currently used. Thus, the findings are ultimately expected to be applicable to the health of human beings.